Research Infrastructure Core

Research Infrastructure Core: Abstract
To support these interdisciplinary research projects, a Research Infrastructure Core has been
designed to provide services in basic research infrastructure, didactic training of RCMI member
researchers, as well as database support, especially in community-based research studies. The
Research Infrastructure Core serving the Center’s projects and pilot projects, has the following
specific aims: 1. Establish core services in human subjects protocol navigation, biostatistics and
clinical database support; 2. Provide training in ethics and responsible conduct of research,
social science research methods, and medical humanities and social stewardship; 3. Provide
infrastructure to enable UCR researchers access to the HARC database and activities to help
map and analyze the relevant health assessment and related data; 4. Launch and support a
Continuity Collaboratory providing fellowship awards to fill gaps in research and database
management in ongoing community-based research projects. Together, the activities of the
Research Infrastructure Core serve multiple components of the HDR@UCR RCMI to insure that
the participating members and trainees are provided with the best support in their training and
research efforts. These activities will support ongoing research, publication, and grant proposal
preparation, and will help establish a sustainable center in support of growth in health disparities
research at UCR.